TransBiota: Genital microbiome, inflammation and HIV risk in trans men and women

SUMMARY
Transgender (trans) individuals are those who have a gender identity that does not match their birth-assigned
sex. About 1.4 million adults in the United States identified as transgender in 2016. Trans people may choose to
medically transition through gender-affirming hormones or surgeries. Trans people are at higher risk for HIV and
other sexually transmitted infections (STI), but little is known of the effect of gender-affirming medical care on
the genital microenvironment, including the microbiome and local immunology, which contribute to HIV and STI
risk in cisgender individuals. The NIH has thus identified a major need for innovative research characterizing the
biological and immunological impact of interventions used for gender reassignment. About ¼ of trans women
(assigned male at birth but with a female gender identity) have undergone vaginoplasty (surgical creation of a
neovagina, typically using penile and scrotal skin), and while these women frequently present with neovaginal
dysbiosis, little is known about the underlying pathophysiology. The penile and vaginal microenvironment in cis
men and women is a critical determinant of HIV and STI risk, yet our understanding of the composition and role
of microbiota colonizing the neovagina is scarce and completely lacking for immune outcomes. In trans men,
vaginectomy is rare (<2%) but an estimated 69% use gender-affirming testosterone therapy. Masculinizing
hormone therapy has significant effects on the vaginal epithelium that result in reduced cellular proliferation and
glycogen production. This is similar to vaginal atrophy observed during menopause in cis women, which affects
the vaginal microbiota and has negative impacts on sexual health and quality of life. Little information is available
on the relationship between vaginal microbiota and inflammation and the development of vaginal atrophy and
HIV and STI risk in trans men. Given these unknowns, the short-term goals of this research are to describe the
neovaginal and vaginal microbiomes in trans women and men, define microbes associated with local
inflammation, and then test for associations between the genital microenvironment and medicines, genital
exposures, and hormone therapy, to guide the development of novel interventions, and clinical and behavioral
best-practices, which currently are lacking. We will achieve these goals by performing a thorough and rigorous
longitudinal description of the vaginal and neovaginal microbiomes in trans men and women (Aim 1) and then
defining the relationship between these microbiomes and the genital immunology, a determining factor of HIV
and STI risk in cis individuals (Aim 2). Our study, TransBiota, will leverage a piloted and validated IRB-approved
innovative home-based sampling strategy and an innovative statistical strategy that affords scientific rigor by
correcting for experimental errors associated with microbiome analyses. Understanding the genital
microenvironment and its role in sexual health in trans women and men is an important prerequisite to achieve
our long-term goals to improve genital care for trans women and men and to ultimately leverage this information
for the development of novel interventions to achieve optimal genital health and protection.

Public health relevance
NARRATIVE The need for innovative research addressing the medical, sociological, psychological and structural causes and consequences of transgender and gender nonconforming identities has been identified by NIH as critical. This research will address this need by developing a better understanding of the vaginal microenvironment (microbiota), behaviors and hygienic practices in trans men and women, and how they drive inflammation and thus the risk of HIV and other STIs. We aim to ultimately develop strategies to improve the sexual health and decrease the risk of HIV/STI in trans men and women.